Cancer under pressure: Mechanisms of adaptation to compressive stress

Project summary
Physical pressure is fundamentally important for cancer biology, but its effects remain poorly understood. When
solid tumors grow confined within surrounding tissue, they build up compressive stress. Given that cells evolved
to function in a stable mechanical environment, even slight changes in pressure perturb physiology. Normal cells
and early stage cancer cells stop growing when pressure builds up. In contrast, in advanced cancer, compression
can change cellular behavior to drive migration of cancer cells to other organs or confer resistance to chemo-
therapy. This difference implies that cancer cells somehow adapt to physical pressure. A lack of tools has slowed
progress in understanding the relationships between compression, the physical properties of cells, and cancer
behavior. We developed two new technologies to overcome this limitation: First, we created a gene that enables
cells to produce a steady supply of fluorescent nanoparticles that act as tell-tales for shifts in intracellular physical
properties. Second, we developed microfluidic devices to control compressive stress, either quickly or slowly,
while maintaining a constant chemical environment. We will combine these innovations to test the overarching
hypothesis that mutations that confer resistance to mechanical compression enable pancreatic cancer cells to
adapt to their high-pressure environment and drive their oncogenic evolution. Aim 1: We will determine how
compression differentially impacts wildtype and mutant pancreatic cells. We will use GEM nanoparticles
to quantify the physical response to pressure and test the hypothesis that oncogenic mutations alter both the
physical and physiological response to pressure. Aim 2: We will determine the effects of compression on
phase separation. We will investigate the hypothesis that decreased cell volume under pressure leads to in-
creased phase separation of stress granules. We will evaluate molecular crowding as a mechanism for these
effects. We will determine the importance of stress granule formation for mechanical adaptation and drug re-
sistance. Aim 3: We will determine genetic mechanisms of pressure adaptation. We will follow up on pre-
liminary mutants that confer resistance to compression, using a CRISPR modifier screen to determine mecha-
nisms of adaptation. We will overexpress known oncogenes to find further adaptation pathways.
Our innovative combination of genetic nanoparticles and microfluidic approaches, and our expertise that
bridges biophysics, mechanobiology and cell biology make us uniquely qualified to connect compression, the
physicochemical properties of cells, and cancer physiology. Our studies promise to reveal key network pertur-
bations essential to cancer cell growth and survival under pressure. Understanding these adaptive mechanisms
promises to suggest treatments that exploit the aberrant mechanical properties of tumors caused by high com-
pressive stress.

Public health relevance
Project narrative Tumor growth leads to the compression of cells as pressure builds up, but we lack of tools to quantify how this stress impacts cancer cells. We have developed devices to apply precise compressive stresses and probes that enable the rapid determination of the physical properties of cells. We will use these new technologies to understand how compression affects the cell interior and elucidate how cancer cells adapt to these perturbations to survive under pressure.